INTERFERON GAMMA TREATMENT OF OSTEOPOROSIS

This investigation was continued to test the hypothesis that treatment with interferon gamma would stimulate bone resorption and white cell function. Results demonstrate that bone resorption is stimulated with a 300% increase in calcium excretion and a 50% reduction in trabecular bone mass. The resultant clinical improvement includes an increase in marrow space, stopping of neurological deterioration and a reduction in serious infections.